UPenn Post Baccalaureate Research Education Program

Project Summary
The objective of the University of Pennsylvania (Penn) Post-baccalaureate Research and Education Program
(PennPREP) is to guide recent college graduates from underrepresented (UR) groups into graduate school to
pursue biomedical research. At least 9 UR scholars are identified each year who are interested in biomedical
research but lack the experience or expertise necessary for graduate school training. Each scholar is matched
with a research mentor among the graduate training faculty and provided with a significant one year (or possibly
longer) research project. An Individual Student Development Plan (IDP) is developed for each scholar to ensure
that the scholar undertakes training appropriate to his or her own scientific needs and interests, including
graduate or advanced undergraduate coursework. Scholars also develop the skills necessary for success in
graduate school by completing workshops in biostatistics, grant writing, the responsible conduct of research,
critical analysis of scientific literature, and oral and written presentation skills. Scholars also participate in a one-
on-one writing workshop with a professional writing instructor. Scholars meet weekly as a group to discuss
scientific journal articles and their own research, in order to further develop their skills in the critical evaluation of
research and the delivery of scientific presentations, as well as to increase their exposure to research outside
their own laboratory. In addition, scholars receive advising for the graduate school application process, including
selecting programs, writing application essays, and practicing interviews. If necessary, scholars will take a GRE
or MCAT preparation course. Scholars also participate in various lunches and seminars with Penn faculty,
postdoctoral fellows and graduate students who share their training experiences, on-going research, and
academic paths. As of 2012, scholars meet annually with scholars, faculty, and advisors of PREP programs at
other institutions in order to network and gain additional perspectives. In addition, all PREP scholars are expected
to attend a national conference each year, such as ABRCMS or a discipline-specific meeting as an additional
means of broadening exposure to research and establishing networks. Several opportunities are in place for
PREP alumni to remain engaged with the program including: (1) PREPConnect, via which PREP alumni connect
virtually (e.g. Skype), once/month with current scholars to offer mentoring and guidance, and (2) the PREP
Alumni Advisory Board, which will meet twice/year to evaluate current programming initiatives, events and
meetings. Mechanisms are in place for measuring the effectiveness of the program's various components and
improving the training experience over time. The ultimate measure of the program's success is the percentage
of scholars who are admitted to PhD or MD-PhD training programs and pursue a research career. Over the past
13 years, 84% (62/74) of PennPREP scholars who have successfully completed the program have been
admitted to PhD or MD-PhD programs. Nineteen of these PennPREP alumni have received the PhD and moved
on to post-doctoral training and/or research careers.

Public health relevance
Project Narrative This program is designed to provide recent college graduates from groups underrepresented (UR) in the biomedical sciences with an intensive research experience, related enrichment activities, and academic advising for a period of a year or possibly longer. The goal of the program is to increase the number of students from UR backgrounds who enroll in a PhD program and pursue a research career. Ultimately, it is expected that an increase in UR biomedical researchers will diversify the biomedical workforce and help to reduce health care disparities.